Molecular Epidemiology of B cell Activation, DNA Repair & HIV-Associated Lymphoma

DESCRIPTION (provided by applicant): This proposal describes a five-year program designed in the short-term to provide additional specific training and mentored research experience to Dr. Shehnaz K. Hussain to enable her to achieve her long-term goal of successfully launching a career as an independent academic researcher and scientist in cancer molecular epidemiology with a focus on infection-related cancers. Dr. Hussain received a Sc.M. in epidemiology from Johns Hopkins, a Ph.D. in epidemiology from U. W. Seattle, was a postdoc at the Karolinska Institute, and is currently a newly appointed Assistant Professor in the UCLA Department of Epidemiology. Dr. Hussain will meet her academic career goals with the help of a highly experienced and supportive interdisciplinary team of mentors including Drs. Zhang (cancer molecular epidemiology), Martinez-Maza (cancer immunology), Detels (HIV/AIDS epidemiology), and Sinsheimer (statistical genetics); a clear and directed career development plan including grant and manuscript writing, didactic training in computational biology, bioinformatics, complex data analysis, and issues in the design/conduct of genome wide association studies, and wet-lab training; a strong and collaborative institutional environment consisting of multiple centers, departments, and schools of UCLA; and a well-defined research project with a high possibility of being developed into an independent research program. The main hypothesis of Dr. Hussain's research project is that adverse genotypes of B cell activation-related genes will be associated with increased risk of HIV-associated non-Hodgkin's lymphoma (AIDS-NHL). Dr. Hussain will conduct a nested case-control study in two well-described HIV cohorts, the MACS and WIHS. TagSNPs in candidate genes, prioritized by putative functionality, will be genotyped in AIDS-NHL cases and matched controls. Multivariate logistic regression models and pathway-based statistical methods will be utilized to determine the association between tagSNPs and haplotypes and AIDS-NHL risk, and to examine whether these associations are modified by other genetic, molecular, or epidemiological factors. This project will integrate high-throughput technologies, innovative statistical methods, and a wealth of previously collected data to extend our understanding of NHL etiology.

Public health relevance
PUBLIC HEALTH RELEVANCE: Non-Hodgkin's lymphoma (NHL) poses an important public health burden in the U.S., which is underscored by the steady rise in incidence and mortality and high number of average years of life lost. Unfortunately, the exact causes of NHL are still largely unknown. Etiological studies of NHL in HIV infected individuals, who are at very high risk of NHL, will inform future strategies for risk assessment, detection, and prevention of NHL. Project Narrative Non-Hodgkin's lymphoma (NHL) poses an important public health burden in the U.S., which is underscored by the steady rise in incidence and mortality and high number of average years of life lost. Unfortunately, the exact causes of NHL are still largely unknown. Etiological studies of NHL in HIV infected individuals, who are at very high risk of NHL, will inform future strategies for risk assessment, detection, and prevention of NHL. __SpecificAimsTextDelimiter__ V. RESEARCH PLAN A. Specific Aims and Hypotheses Non-Hodgkin's lymphoma (NHL) poses an important public health burden in the U.S., which is underscored by the steady rise in incidence and mortality over the past several decades and high number of average years of life lost per NHL death. Unfortunately, the exact causes of NHL are still largely unknown, although severe immunodeficiency, various infectious agents, and a positive family history of NHL are consistently associated with increased risk. In fact, HIV positive individuals have a greatly increased risk of NHL, on the order of 80- fold the population risk, thus HIV positive populations provide a unique setting and opportunity for research into the role of immune dysfunction in NHL pathogenesis. Two biological mechanisms are thought to be responsible for the increased NHL risk among HIV positive individuals; 1) loss of immunoregulation of EBV infected B cells, and 2) chronic B cell hyperactivation. The latter is associated with somatic mutation and repair of the immunoglobulin gene through two pathways, somatic hypermutation (SHM) and class switch recombination (CSR). There is substantial evidence to suggest that oncogenes and tumor suppressor genes may be targets of misdirected SHM and CSR which could predispose B cells to lymphomagenesis. The main hypothesis of this proposal is that adverse genotypes and haplotypes of B cell activation pathway-related genes will be associated with risk of HIV-associated NHL, possibly by influencing the expression of key B cell activation factors. To test this hypothesis, we will utilize the resources of two well-characterized large prospective cohort studies of the natural and history of HIV and AIDS, the Multicenter AIDS Cohort Study (MACS) and the Women's Interagency HIV Study (WIHS), to conduct a nested case-control study. The specific aims of this proposal are as follows: (1) To determine a minimal set of tagSNPs for candidate genes in B cell activation pathways through analysis of linkage disequilibrium patterns in genotype data obtained from publicly available databases. Furthermore, to increase the probability that functionally relevant polymorphism will be selected and genotyped as one of our tagSNPs, in silico analyses will be performed such as comparative genomic analyses, identification of binding sites for transcription factors and other regulatory factors, and the analysis of functional relevance of amino acid substitutions. (2) To determine whether tagSNPs and haplotypes in candidate genes are associated with development of AIDS-associated NHL, and whether these associations are modified by epidemiological factors (e.g. age and cigarette smoking habits), HIV-progression related factors (e.g. anti-retroviral therapy, HIV load, CD4+/CD8+ T cell number), tumor specific factors (e.g. NHL subtype and tumor EBV status), molecular markers (e.g. EBV load and serum cytokine/chemokine levels), and polymorphisms in other candidate genes (e.g. cytokines, chemokines, and inflammatory markers) potentially related to B cell activation, utilizing multivariate logistic regression models and additional pathway-based modeling and data-reduction techniques. (3) To examine the association between tagSNPs and haplotypes in candidate genes of the B cell activation pathway and two NHL susceptibility biomarkers: Activation induced cytidine deaminase expression in peripheral blood mononuclear cells and circulating serum levels of the chemokine CXCL13. In this proposal, we will integrate a wealth of previously collected epidemiological, clinical, molecular, and genetic information on cohort members, high-throughput genotyping, and innovative statistical methods to extend our current understanding of NHL etiology. Furthermore, we will have a unique opportunity to confirm or refute the results from this study through a collaboration with a consortium incorporating approximately 1,000 cases of HIV positive NHL and 1,000 HIV positive matched controls, the North American AIDS Cohort Collaboration on Research and Design (NA-ACCORD). By assessing the association of genetic variation in a putatively important etiologic pathway in NHL and NHL risk in a large population of individuals at high risk, we hope to identify inherited factors that ultimately will be found to be important in NHL pathogenesis, and thus of potential importance to risk assessment, early detection, prevention, and development of therapeutics.